Personalized genomics signal deconvolution to improve cell-type level inference

Abstract:
The real-world clinical bulk sequencing samples contain mosaics of various cell types. The recent success of
signal deconvolution methods demonstrated that properly accounting for cell type mixture proportions leads to
improvement in biomarker discovery and better interpretations at cell-type resolution. The current statistical
methods, however, are all based on a very strong assumption that a common reference panel is shared across
the whole population. This deviates from the biological fact that person-to-person heterogeneity exists, even at
cell-type level. To address these issues, I propose to develop a series of novel statistical methods to conduct
deconvolution at the `personalized + cell-type' level. I will properly model the admixture data, retrieve individual-
specific and cell-type-specific reference panels, use them to improve cell type proportion deconvolution, and
conduct statistical rigorous test to identify cell-type-specific differentially-expression genes. First, leveraging on
temporal or repeatedly measured data, we will develop a mixed-effect model based iterative algorithm, to extend
the current cell type mixture modeling by allowing for personal-level reference panels. We will obtain individual-
specific and cell-type-specific reference estimation, to retrieve more accurate, personalized gene expression
profiles. Next, we will develop a statistical framework to deconvolute samples with repeated measures, to im-
prove the cell type proportion estimation. We will also conduct wet-lab experiments to validate our statistical
methods. Third, we will develop methods to test for cell-type-specific differentially expressed genes, by incorpo-
rating individual-specific reference panels. We will also compile existing tools that can conduct cell-type-level
differential expression gene analysis in the bulk data, benchmark them, and develop methods to evaluate the
statistical power. Finally, we will apply the proposed methods to analyze the bulk transcriptome data from The
Environmental Determinants of Diabetes in the Young (TEDDY) for type 1 diabetes research, from Parkinson's
Disease Biomarkers Program (PDBP), and other large consortia with longitudinal bulk samples. Our methods
and software packages will provide important resources that enable new biomedical genomics studies, such as
biomarker discovery of individual cell-type transcriptomics/epigenetics biomarkers associated with environmen-
tal factors, or disease risk prediction using cell type related profiles and proportions. Our proposed work will
significantly enhance our abilities to re-analyze and re-use bulk sequencing data, enhance the utility of decon-
volution to a `personalized + cell-type' level, and have major impact on the cell-type-specific data mining and
inference in clinical settings.

Public health relevance
Project Narrative: Clinical bulk samples contain mixed cell types, resulting to an admixture of signals from multiple pure compo- nents. We propose to develop novel statistical approaches to address the problem of cell type mixture identifi- cation for subjects with multiple observations, construct methods to estimate individual-specific pure profile ref- erences, and retrieve more accurate cell type mixture proportions at individual levels. Our project will break new ground for many studies by enabling the investigation of personalized pure cell type associations with the disease outcome, and the individual-level, cell-type-specific biomarker discovery.